Collaborative Health Research Initiative Program (CHIRP)

To recognize the strategic and scientific implications of research in heart, lung, blood, and sleep disorders across the research continuum from basic to late-stage translational research. Health inequities research, implementation science, and trauma research